RANDOMIZED COMPARATIVE TRIAL OF ZDV VERSUS DDI VERSUS ZDV PLUS DDI IN HIV

A multicenter randomized, double-blind comparative trial of ZDV vs. ddI vs. ZDV plus ddI in HIV infected infants and children without prior antiretroviral therapy.